DNA MARKER STUDY OF LINKAGE TO SCHIZOPHRENIA IN CROATIA

The proposed project will use the Psychoses Register and other data resources at the institute of Public Health of the Socialist Republic of Croatia in Yugoslavia to establish a family data bank with high-density pedigrees, affected sib-pairs, and other pairs, of affected relatives with schizophrenia for the purpose of conducting DNA marker linkage studies. In this application for an initial three-year period, we are proposing (1) to screen the Psychoses Register and supporting files to identify schizophrenic probands with affected family members and to establish the family data bank on a PC, (2) to train the Yugoslavian Co-investigators and other clinicians who will be conducting diagnostic interviews in the use of structured interviews and ratings according to DSM-IIIR and the RD C. (3) to conduct diagnostic interviews and collect blood samples from approximately 490 individuals (schizophrenic probands and their relatives), (4) to begin work-up of the blood samples in the Molecular Genetics Laboratory, Department of Medical Genetics, New York State Psychiatric institute, immortalize cell lines, and begin the assay of DNA markers (candidate genes, chromosome 5 probes, etc.), and (5) to begin in preliminary linkage analyses according to any of several methods, as appropriate to the family structures that are identified.